Post-translational regulation of alpha PSM production in Staphylococcus aureus by the small RNA Teg41

PROJECT SUMMARY/ABSTRACT
Staphylococcus aureus is both a commensal of humans and a highly dangerous bacterial pathogen. S. aureus
pathogenesis is mediated by a large repertoire of secreted and cell wall-associated virulence factors, including
a number of potent cytolytic peptides called phenol soluble modulins (PSMs). PSMs are amphipathic, alpha
helical peptides that vary in size depending on their classification. The α type PSMs are ~22 amino acids in size
and have been the focus of intense study in recent years. They have been implicated in contributing to the high
virulence potential of community-acquired methicillin resistant S. aureus (CA-MRSA) strains, in particular those
of the USA300 lineage. While the role of αPSMs in S. aureus infection has been extensively investigated,
significant gaps still exist in our understanding of how they are produced in the bacterial cell. There are five
αPSM peptides produced by most S. aureus strains (PSMα1-4 and the δ-toxin). PSMα1-4 are encoded within
the same polycistronic transcript (the αPSM transcript), yet studies have shown that the relative levels of the four
peptides vary considerably. PSMα4 (located at the 3' end of the transcript) is commonly the most abundant,
while PSMα3 (the most potent of the four peptides) is typically the least abundant. This variation in αPSM
abundance is suggestive of post-transcriptional regulation. The long-term objective of this project is to
understand the molecular mechanism(s) that contribute to αPSM production in S. aureus. In this proposal, we
will specifically investigate the contribution of the small RNA Teg41 to αPSM production and virulence.
Preliminary studies show that Teg41 positively influences αPSM production at the post-transcription level. We
will investigate (i) which of the PSMα1-4 peptides is/are regulated by Teg41, (ii) if Teg41-mediated regulation is
facilitated by direct base pairing with the αPSM transcript, and (iii) at what stage in αPSM production, and how,
Teg41 exerts its influence. To investigate these three aims, we will use a combination of in vitro, in vivo, genetic,
biochemical, and molecular biology approaches. We will also utilize a number of cutting edge techniques based
on high throughput DNA sequencing (SHAPE-seq, miR-CATCH, and Ribo-seq). The results from this study could
have direct implications for human health. Disrupting Teg41-mediated αPSM-production could dramatically lower
the virulence potential of S. aureus and therefore may represent a novel target for therapeutic intervention.

Public health relevance
PROJECT NARRATIVE Staphylococcus aureus produces a number of toxic peptides, called alpha phenol soluble modulins (αPSMs), that contribute to virulence. We have identified a regulatory RNA molecule, called Teg41, that plays a critical role in virulence by positively influencing production of the αPSMs. In this proposal we will investigate the mechanism of action of Teg41, determine how it influences αPSM production, and examine how disrupting the Teg41:αPSM interaction impacts the ability of S. aureus to cause disease.